Coronary Magnetic Resonance Angiography

Project Abstract
The goal of this project is the robust, noninvasive magnetic resonance (MR)
imaging of the proximal coronary arteries in humans. MR is a dynamic modality
that offers enormous flexibility to deal with the considerations involved in
coronary artery imaging, including resolution (spatial and temporal) and motion.
Improvements in MR hardware, pulse sequences, and data processing
algorithms have led to advances in coronary magnetic resonance angiography
(CMRA). However, further improvements in image quality and consistency are
needed to raise CMRA to the level of clinical utility.
The proposed research plan involves the development and evaluation of new
methods for CMRA. Key components include a novel 3D cones trajectory for fast
whole-heart imaging, and high-quality 3D image-based navigators (iNAVs) every
heartbeat for monitoring motion in every region of the heart. Compared to
conventional CMRA methods, non-Cartesian 3D cones scanning offers higher
scan efficiency and improved motion performance in the heart. Compared to
conventional navigator methods, 3D iNAVs provide much greater information
about heart motion during the scan. Major enhancements to CMRA will be
investigated in this project, including those for higher resolution and more robust
motion detection-compensation. Following a period of technical development and
preliminary evaluation, a comparative study of the optimized CMRA method with
x-ray angiography (stenosis and fractional flow reserve measurements) will take
place on patients with suspected coronary artery disease.

Public health relevance
Project Narrative Because coronary artery disease remains the leading cause of death in the United States, the development of a noninvasive method to image the coronary arteries in patients with this disease would have a major impact on healthcare. This project seeks to attain this goal using magnetic resonance imaging (MRI), a safe, painless, and radiation-free technology. This research will develop, optimize, and evaluate new MRI methods designed to produce images of the coronary arteries reliably.